Frailty, Aging, and Risk of Adverse Outcomes in Mitral Valve Prolapse (FAR-OUT-MVP Study)

PROJECT SUMMARY
Mitral valve prolapse (MVP) is a common cardiac valvular disease, with a prevalence of roughly 2-3% in the
general population, associated with excess mitral valve or chordal tissue may predispose to the development
of mitral regurgitation (MR) from leaflet malcoaptation and chordal rupture. This condition and its sequelae,
detected on echocardiograms (TTEs) and cardiac magnetic resonance images (CMRs), has been previously
felt to be associated with an overall benign prognosis. Recent evidence suggest a subset of individuals with
MVP have an excess risk of cardiovascular and non-cardiovascular morbidity and mortality, including
ventricular arrhythmias and sudden cardiac death. Despite known risks of MVP, it remains challenging to
identify high risk subsets in need of further treatments such as implantable defibrillator use or mitral
valve repair or replacement. Furthermore, disaggregating the risk of MVP from that of concomitant MR
remains challenging at present. Moreover, while individual imaging biomarkers of risk have been identified,
which of these independently influence MVP risk when considered together remains unclear. While relevant
clinical risk factors including aging and frailty, “a state of increased vulnerability and reduced ability to maintain
homeostasis after a stressful event resulting from an impairment in multiple physiologic systems,” have found
to influence outcome risk in other valvular heart diseases, it remains unclear if aging and frailty modify the risk
of MVP on adverse outcomes. This proposal leverages the unique linkage of two large data sources,
structured datasets of TTE and CMR reports from Beth Israel Deaconess Medical Center, and all-payer
statewide claims data from the Massachusetts Case Mix Dataset (MACM) to better evaluate the risk of MVP
across the spectrum of age and frailty. In this study, we propose to directly link BIDMC TTE and CMR reports
to MACM data to evaluate whether MVP is associated with a risk of mortality, cardiovascular morbidity
(composite of heart failure, atrial fibrillation, cerebrovascular event, endocarditis), and need for mitral valve
replacement or repair, and whether this risk relationship varies by age and frailty as well as operative status
(receipt of mitral valve replacement or repair). Doing so, this study will provide greater insight into the
role that aging and frailty may have on the risk of serious outcomes associated with MVP and build a
unique registry of cardiac imaging information linked to outcome data that could be leveraged in the
future to deepen understanding of MVP as well as other valvular heart diseases.

Public health relevance
PROJECT NARRATIVE Mitral valve prolapse (MVP), the finding of excess mitral valvular or chordal tissue, is a common valvular disease, which may lead to blood flowing backwards during the heart’s contraction and multiple associated risks. In other valvular diseases, aging and frailty, a reduced ability to recover after a stressor (e.g. an illness), have been associated with an increased risk of adverse outcomes, but it remains uncertain how aging and frailty impact the risk associated with MVP. This study uses the linkage of two unique data sources, imaging information from cardiac magnetic resonance images and echocardiograms from Beth Israel Deaconess Medical Center, and Massachusetts all-payer claims data to understand how the risks of adverse outcomes associated with MVP vary according to an individual’s age and underlying frailty status.